Genetic Architecture of Aging-Related TDP-43 and Mixed Pathology Dementia

Aging-related dementia is highly heritable, yet a large proportion of this genetic risk remains unexplained. In
>30% of aged individuals with clinical dementia, autopsy reveals TDP-43 pathology – an enormous and under-
acknowledged public health problem. A term for this prevalent non-Alzheimer’s amnestic dementia-associated
condition was recently proposed: limbic predominant age-related TDP-43 encephalopathy (LATE). There is
great clinical and pathologic heterogeneity among individuals with LATE pathology. Some affected individuals
have a rapid and devastating clinical course, whereas others have relatively benign symptoms. Both the severity
of TDP-43 pathology and the presence of comorbid pathologies appear to be key determinants of clinical
outcomes in LATE. We have generated exciting preliminary data that indicate distinct (and pleiotropic) genetic
risk factors for LATE and associated pathologies. However, there is still an incomplete understanding of the
genetic determinants of these brain diseases. To address this knowledge gap, we will develop a robust analysis
pipeline (leveraging extensive prior work and resources) using data-driven methods to classify pathology
progression and novel statistical methods to analyze genetic risk/protective factors.
AIM 1: Assemble multimodal datasets (including clinical and genetics data) for testing novel hypotheses
about LATE pathogenesis and develop rubrics for “pure” and “mixed” subtypes of pathology
We will leverage extensive data processing resources to derive and test a pathological classification system
optimal for research at the nexus between genetic risk and neuropathologic endophenotypes. Key
endophenotypes in the dataset will include digital neuropathologic assessment of pathologies. Through these
studies, we will gather and curate clinical, genetic, and pathological information on diverse populations.
AIM 2: Identify genetic regions associated with aging-related TDP-43 brain pathology, i.e., LATE
We will employ genome-wide and targeted association testing, predicted quantitative trait loci (QTL) detection,
and subsequent colocalization. Preliminary results demonstrate that our goals are broadly achievable given our
study sample sizes. A set of LATE risk factor genes has been discovered by us and others,2-6 including proof-of-
concept: a LATE neuropathology gene previously linked to clinical Alzheimer’s disease (WWOX).7
AIM 3: Identify genetic regions and biologic pathways associated with LATE-associated neuropathologic
endophenotypes: coexisting hippocampal sclerosis, arteriolosclerosis, and Alzheimer’s disease
We will test the hypotheses that comorbid LATE-related phenotypes share genetic predisposition and can be
treated as subtypes. Further, underlying pathways are discoverable with multivariate methodologies. We will
expand our understanding of the genetic risk factors, disease-associated pathways, and the potential for
modifying those pathways. We will develop and employ multivariate, clustering, and individual-specific network
methods to infer pathways driving LATE-related pathologic phenotypes.

Public health relevance
PROJECT NARRATIVE Aging-related dementia is caused, at least in part, by a person’s genes; exactly which genetic variants are responsible for this remains largely unknown. This project uses new and existing data to precisely identify the genetic causes of a form of non-Alzheimer’s disease dementia known as limbic predominant age-related TDP-43 encephalopathy (LATE). Understanding the genetic roots of LATE will shed considerable light on the mechanisms of the disease which can, in turn, be leveraged to develop new modes of prevention and treatment, thereby reducing the considerable burden this disease has on public health.